Mortality in Autism

The long-term objective of the proposed project is to reduce excess mortality and improve life expectancy for
people with autism spectrum disorder (ASD). The specific aims are to: 1) determine age- and sex-specific
mortality risk in Medicaid beneficiaries with and without ASD; 2) examine cause-specific mortality risk in
Medicaid beneficiaries with and without ASD; 3) identify effect modifiers (e.g., gender and intellectual disability)
of mortality risk associated with ASD; and 4) assess racial and ethnic disparities in mortality risk in Medicaid
beneficiaries with and without ASD. In the United States, the reported prevalence of ASD among children aged
8 years has more than tripled over the past two decades, increasing from 6.7 per 1,000 in 2000 to 23.0 per
1000 in 2018. There were an estimated 6.9 million persons with ASD in the United States, including over 1.5
million children aged 3-17 years and 5.4 million adults aged 18-84 years. As a complex neurodevelopmental
disability, ASD often requires extensive lifetime health care and social services. Research on ASD has been
largely concentrated in understanding its biology, identifying risk factors, monitoring prevalence in children, and
evaluating treatments and interventions. Although substantially reduced life expectancy for individuals with
ASD has been speculated since the early 1990s, research on mortality and lifespan issues in autism remains
scant. Medicaid, including the Children’s Health Insurance Program, is the primary public insurance program
for individuals with ASD. The proposed project involves constructing a dynamic cohort of about 1 million
Medicaid beneficiaries with ASD and about 4 million Medicaid beneficiaries without ASD (two million matched
with the exposed cohort on state, year of enrollment, age at enrollment, and sex; and two million matched
additionally on type of eligibility) and analyzing longitudinal data over a 24-year study period (1999–2022).
Results from the proposed project will provide much-needed epidemiologic evidence for understanding the life-
course mortality risk, causes of death, effect modifiers of mortality risk, and racial and ethnic disparities in
mortality risk associated with ASD, and for developing effective interventions to reduce excess mortality and
informing health policy and service planning for people with ASD.

Public health relevance
Individuals with autism spectrum disorder (ASD) are more likely to die prematurely and may have considerably shorter life expectancy than the general population. The proposed project aims to assess the mortality risk and causes of death in about one million Medicaid beneficiaries with ASD compared with four million Medicaid beneficiaries without ASD. Findings from this project will help advance our understanding of the natural history and long-term prognosis of ASD and facilitate the development of effective strategies and interventions to reduce excess mortality associated with ASD.